A Patient-Centered Approach to Integration of Life Expectancy into Treatment Decision Making for Patients with Genitourinary Malignancy

PROJECT SUMMARY
Life expectancy (LE) is a critical factor in treatment decision making for men with genitourinary (GU)
malignancies, since limited LE predicts lower likelihood of sufficient longevity to benefit from treatment, higher
morbidity after treatment, and decreased effectiveness of treatment. Despite a prominent role of LE in
guidelines, patients with limited LE are often overtreated for indolent cancers and undertreated for high-risk
cancers. Data from non-cancer treatment settings suggest that this may be due to physician-level barriers
precluding effective communication of LE. Surprisingly little is known about how LE is currently communicated
in treatment consultations as well as patient and physician perspectives on how it should be ideally integrated.
Furthermore, patient and community opinions on what LE cutoffs are best suited to “non-aggressive treatment”
are lacking. In this application, we propose a series of incremental studies with an overarching goal of building
a patient-centered approach to integrating LE into treatment decision making for patients with prostate, kidney,
and bladder cancer. (1) First, we will delineate how LE is currently communicated to patients with GU cancers
through qualitative analysis of treatment consultation transcripts of patients with early-stage prostate, kidney,
and muscle-invasive bladder cancer. We believe that the current communication of LE will be highly variable in
terms of incidence of discussion, mode of communication, temporal positioning within the visit, emotive
context, and time devoted to the topic. (2) Second, we will engage patient and specialist physician
stakeholders through structured interviews to identify barriers and opportunities to improve communication
information about LE in cancer treatment decision making. (3) Third, we will use online crowdsourcing of
conjoint analysis (CA) as a platform to study how patients and the community value LE relative to other
tradeoffs typically encountered in prostate, kidney, and bladder cancer treatment decision making. We will
analyze crowdsourced conjoint analysis data to identify situations (based on age, comorbidity, and tumor risk)
where LE appears to drive “non-aggressive” treatment choices, which will allow for targeting of LE
interventions. (4) Fourth, we will test in a randomized trial whether patient-specific LE estimates—
communicated in a patient-centered approach as determined in the first and second aims and targeted to
specific high-yield situations as identified in the third aim—along with LE-specific conjoint analysis data
improve decisional conflict, quality of LE data discussed, and reduce overtreatment of GU malignancies. We
anticipate that this patient-centered approach will improve shared decision making and ultimately result in
better treatment choices for patients with GU cancers and limited LE.

Public health relevance
PROJECT NARRATIVE This mixed methods study aims to develop and test a patient-centered approach to integrating life expectancy (LE) into treatment decision making for patients with early stage prostate and kidney cancer and muscle- invasive bladder cancer. We will: define how LE is currently communicated in treatment counseling discussions; obtain patient and physician perspectives on how it should be ideally communicated; use online crowdsourcing of conjoint analysis tools to identify consensus between patients and the community regarding which LE cutoffs are best suited to “non-aggressive” treatment; and test whether targeted, patient-centered communication of LE data, paired with conjoint analysis data on LE, reduces decisional conflict and overtreatment of genitourinary malignancies. By using empiric data to guide a patient-centered approach to communication of LE data, we believe that we will optimize its impact on shared decision making and thereby reduce over- and undertreatment of patients with genitourinary malignancy and limited LE.